Promoting Rigor and Reproducibility in Rodent Models of Metabolic Disease through Thermoneutral Housing

PROJECT SUMMARY
Preclinical research relies heavily on appropriate animal models to better understand human biology and to
test the safety and efficacy of new therapies. It is important that animal research cores continually strive to
optimize preclinical models, both from an animal welfare standpoint and to promote rigor and the translatability
of preclinical data.
Rodents are thought to represent around 97% of the vertebrate animals used in biomedical research in the US.
Guidelines in the US recommend housing laboratory rodents at temperatures ranging from 20°C to 26°C.
However, there a growing body of data indicating that housing temperatures in the low to mid-20°Cs
represents mild cold stress for rodents. Critically, compared to housing animals at thermoneutrality, sub-
thermoneutrality can fundamentally change rodent physiology to a degree that can impact disease
susceptibility and/or the efficacy of specific therapies. Accordingly, the utility and importantly the translational
value of preclinical rodent models is dependent on appropriate control of housing temperature.
The goal of this application is to acquire modern rodent housing cabinets that will advance research-related
operations within the animal core at Arkansas Children’s Research Institute by providing a cost and energy-
efficient means to breed, house, and study rodents at temperatures that promote the rigor and translatability of
resulting data.

Public health relevance
PROJECT NARRATIVE Rodents represent around 97% of the vertebrate animals used in biomedical research in the US, yet standard housing guidelines typically expose rodents to cold stress. Growing evidence indicates that the translational value of rodent models of human disease is dependent on housing temperature, a variable seldom controlled for in biomedical research. The goal of this application is to acquire modern rodent housing cabinets that will advance research-related operations within the shared-use rodent metabolic and behavioral phenotyping core at Arkansas Children’s Research Institute. These housing cabinets offer an innovative and energy-efficient mean for breeding, housing, and studying rodents at appropriate housing temperatures.